Yoga for Chemotherapy-induced Peripheral Neuropathy Treatment (YCT) Trial

PROJECT SUMMARY
Chemotherapy-induced Peripheral Neuropathy (CIPN) is one of the most harmful, common,
painful, and disabling side effects of many chemotherapy agents and there is no effective
treatment for it. Our pilot phase IIB two-arm trial showed that yoga treatment is associated with
reduced CIPN pain and reduced risk of falls compared to usual care control. We aim to
increase cancer patients’ function and quality of life by identifying effective treatments to
alleviate chemotherapy-related toxicities. The goal of the proposed project is to determine the
efficacy of yoga in treating CIPN pain and improving function, as well as to improve sensory
nerve recovery and reduce the risk of falls in cancer survivors suffering from moderate to
severe CIPN pain. We will conduct a phase III, randomized, education and usual care-
controlled trial with 268 participants to: 1) determine the efficacy of an eight-week yoga
treatment on CIPN symptoms among cancer survivors with moderate to severe CIPN pain; 2)
evaluate the effect of yoga versus education control and usual care on improving flexibility and
reducing the risk of falls; and 3) evaluate the effect of yoga versus education control and usual
care on quality of life and sensory fiber functioning.

Public health relevance
PROJECT NARRATIVE The findings from this study will help determine the efficacy of yoga for reducing chemotherapy- induced peripheral neuropathy pain when compared to education and usual care control groups. It will also help evaluate yoga’s effect on improving quality of life, sensory nerve recovery, and reducing the risk of falls. The study findings may contribute to identification of a non- pharmacological method to improve patients’ quality of life and prevent falls.